Defining the Functions of Entero-Mammary T cells in Lactogenesis and Maternal-Offspring Immunity

Project Summary / Abstract
The entero-mammary axis, which is the interaction between the intestine and the mammary gland, is crucial for
maternal protection of offspring. In changing environments, mothers must provide appropriate nutritional and
immune support, but the mechanisms by which they shape milk composition and ensure immune protection for
their offspring remain poorly understood. The broad, long-term goal of this application is to enhance our
understanding of how entero-mammary communication improves maternal-offspring immunity. This has
significant implications for maternal and offspring health, such as reduced risk of chronic diseases in both, and
stronger intestinal immunity in the offspring, aligning with the NIAID's mission to improve health outcomes
through research on infectious and immunologic conditions. The objective is to investigate the functions of
specialized intestinal T cells, called intraepithelial lymphocytes (IELs), that are recruited to the mammary gland
during lactogenesis. Our central hypothesis is that entero-mammary IELs promote maternal-offspring immunity
by regulating milk-producing mammary epithelial cells and shaping milk composition. The rationale is that
identifying the mechanisms by which IELs regulate milk composition could lead to strategies for enhancing
maternal immunity, improving breastfeeding outcomes and boost offspring health in early life. The specific aims
of this study include 1) investigating how IELs influence milk metabolites to modulate offspring health and support
the recovery of mammary epithelial cells after infection or injury during lactation, 2) mapping interactions between
IELs and epithelial cells, including TCR-specific entero-mammary IELs, to understand regulatory mechanisms
of IELs, and 3) determining the effects of maternal influences, such as diets, infections, and reproductive
hormones on entero-mammary IEL dynamics during lactation and as a result, offspring health. Several cutting-
edge techniques will be employed to perform this study, including in-vivo labeling of cells followed by single cell
RNAseq, spatial transcriptomics, metabolomics, TCR engineering, and spectral flow cytometry. The successful
completion of these studies will establish the role of the recently identified entero-mammary IELs in lactogenesis,
as well as pinpoint the mechanisms by which these cells regulate mammary epithelial cells, uncovering a novel
function of IELs. This proposal is highly innovative as it explores the largely uncharted territories of the entero-
mammary axis and immune cell involvement in enhancing milk composition, leading to healthy immune
development in offspring. By examining how immune cells, particularly T cells, regulate lactogenesis, this
research will pave the way for a burgeoning field with significant implications for maternal-offspring immunity.
This study will make a substantial contribution to the fields of maternal and child health, as well as intestinal
immunity, mammary immunity, and infectious disease research, by revealing the intricate interplay between
immune cells and milk production during lactation.

Public health relevance
Project Narrative The proposed research is relevant to public health as it seeks to uncover the mechanisms by which maternal immune cells regulate milk composition and influence offspring immunity, which could help reduce the incidence of chronic diseases. By enhancing understanding of the entero-mammary axis, the findings may inform strategies to optimize maternal nutrition and immune function during lactation, ultimately improving health outcomes for both mothers and children. This knowledge can contribute to reducing healthcare burdens associated with early- life infections and chronic intestinal diseases and promote healthier populations across generations.